ENTERAL FEEDING IN PATIENTS WITH SHORT BOWEL SYNDROME

Evaluates whether formula osmolality, intestinal contact time, and the amount of dietary fat has an impact on stool volume and nutrient absorption in patients with short bowel syndrome.